Optimizing Osteoarthritis Care through Clinical and Community Partnership

Many studies have documented deficiencies in quality of care for knee and hip osteoarthritis (OA), particularly
with respect to lifestyle (e.g., weight management and exercise) and rehabilitative components, which are
“strongly recommended,” first-line treatments. Primary drivers of these deficiencies in care are the lack of
standardized models for OA management and the limited time available during routine clinic visits to address
non-pharmacological aspects of OA care. The long-term goal of our research is to conduct a rigorous, multi-
site randomized controlled trial (RCT) of a guideline-concordant OA care model, built on clinic-community
partnership and designed for widespread implementation and sustainability in the U.S. The OA Clinic-
Community CARE Model (OA CARE) will address all recommended components of knee / hip OA care,
include interventions for both patients and primary care providers (PCPs), and utilize a tailored approach that
efficiently matches treatments with patients’ needs. The patient component of OA CARE will include evidence-
based weight management and exercise programs for all participants (delivered through the YMCA), as well as
tailored referrals to physical therapy, additional weight management or nutrition services, sleep-related
services and psychological services. The PCP component of OA CARE will include a video-based summary of
current OA treatment guidelines (with emphasis on practical application), collaboration on patients’ referrals to
specific services described above, and progress reports on enrolled patients. This exploratory clinical trial will
achieve critical steps toward conducting a multi-site RCT of OA CARE. We will enroll 60 patients with
symptomatic knee or hip OA and overweight / obesity who are not currently meeting physical activity
recommendations. Participants will be randomized to OA CARE or a usual care control group. We will
accomplish the following specific aims: Aim 1. Assess the feasibility and acceptability of OA CARE.
Feasibility metrics will include recruitment rate, completion rates for weight loss and exercise program visits to
the YMCA, utilization of tailored services and proportion of participants completing follow-up assessments.
Acceptability of OA CARE will be evaluated from both patient and PCP perspectives. Aim 2. Obtain preliminary
data on the efficacy of OA CARE with respect to the primary outcome of change in total Western Ontario and
McMaster Universities Osteoarthritis Index (WOMAC) score. The WOMAC will be administered at baseline, 6-
months and 12-months, along with secondary outcomes including body weight, physical activity, physical
function, sleep and psychological measures. Outcomes will be statistically analyzed between groups across
the follow-up time points using general linear mixed models.

Public health relevance
Exercise, physical therapy and weight management are all recommended treatments for people with hip or knee osteoarthritis (OA), but studies show that these therapies are often not included in care for OA. The objective of this study is to test an OA Clinic-Community CARE Model that will address all components of OA treatment guidelines, involve interventions for both patients and health care providers, and partner with a community organization to deliver exercise and weight management interventions. We aim to develop a care model that can be used widely in the US and enhance care for many people with hip and knee OA.